Optimizing bone surface targeting of therapeutic antibodies for osteoporosis

PROJECT ABSTRACT
Osteoporosis is the most common bone disease, affecting an estimated 10 million adults in the US alone and
causing millions of fragility fractures each year. Existing therapies are plagued by low rates of treatment and
poor adherence, largely due to concerns regarding infrequent but serious toxicities. Our way of improving the
safety profile of osteoporosis therapies is to increase their local concentration by targeting them to bone. Our
laboratories have recently developed technology which increases bone surface delivery of monoclonal
antibodies (IgGs) by orders of magnitude and shown that this approach enhances the efficacy of a clinically
relevant anti-sclerostin antibody (anti-Scl), while allowing lower dose and less frequent administration. The
central hypothesis of the current proposal is that optimization of bone surface targeting parameters will
enable local delivery of a wide range of therapeutic IgGs to both normal and osteoporotic bone, while
ensuring target engagement and minimizing localization to areas of extraskeletal calcification. In Aim 1, we
will optimize the pharmacokinetics (PK) and pharmacodynamics (PD) of anti-Scl in both healthy mice and
animals with an ovariectomy induced model of osteoporosis. We will then conduct a pre-clinical trial of the
optimal form of targeted anti-Scl in animals with established osteoporosis, using a variety of translationally
relevant endpoints. In Aim 2, we will optimize bone surface delivery of another IgG with clinical relevance in
osteoporosis, anti-RANKL, which we hypothesize will require intermediate binding to the bone surface in
order to allow optimal target engagement. Finally, in Aim 3, we determine if bone surface targeting of IgGs
also induces accumulation in areas of extraskeletal calcification. We will vary bone surface targeting
parameters and determine their impact on the localization of targeted anti-Scl, as well as its impact on the
rate of vascular or valvular calcification. Key expected outcomes include optimized forms of anti-Scl and anti-
RANKL which may be rapidly translated to large animal models and future clinical trials in osteoporosis.

Public health relevance
PROJECT NARRATIVE The focus of this research proposal is the delivery of therapeutic antibodies to the bone surface for the treatment of osteoporosis. We have demonstrated successful bone targeting of a clinically-used antibody and shown that it enhances its efficacy while allowing lower and less frequent dosing. In this project, we will further optimize our bone delivery technology, determine if it can be applied to other clinically-relevant antibodies, and ensure that it does not inadvertently target antibodies to other mineralized areas in the body, like calcified blood vessels or heart valves.